Leveraging Artificial Intelligence for the assessment of severity of depressive symptoms

Depression is one of the leading causes of disability worldwide, affecting an estimated 300 million people.
Evidence-based treatments are available and measurement-based care has been described as the gold
standard. Monitoring of depressive symptoms is currently performed with self-administered and interview-
based assessment methods conducted by clinicians in their offices. However, the shortage of mental health
specialists and the limited resources available to primary care physicians who often manage patients with
depression, prevent close monitoring of symptoms delaying optimal treatment potentially prolonging
suffering. Passive recording of behavioral data (gathering information without individual's direct input) has
been identified as a potentially feasible method for long-term monitoring of depression. To date, most studies
have collected passive behavioral data in "real time" through mobile apps (i.e. accelerometer, phone clicks)
with the goal of identifying potential markers of depression. However, this method lacks critical biological
indicators of depression, including sleep, arousal, and motion. Recent development in wristband sensor
technology developed by out lab has allowed to measure physiological parameters like gait, heart rate
variability (HRV) and electrodermal activity (EDA) continuously in “real time”, allowing a broader anatomical
and neurophysiological understanding of emotion, behavior, and cognition in mood disorders as they occur
during routine activity. During the past decade, along with the development of sensors, we have seen the
progressive use of machine learning, a branch of artificial intelligence that enables the detection of complex
patterns in multimodal data, allowing the development of complex models. The combination of sensor
technology and machine learning allows detailed measurement in real time of a wealth of behaviors predicting
mood variation. Over the past 2 years, our interdisciplinary team, including one of the leading lab on
depression research, and one of the most innovative lab on affective computing, has conducted a study
applying machine learning analytics to create a model combining wristband sensors data and phone-
based passive measurements to assess severity of depressive symptoms. In our pilot study with depressed
patients monitored over 8 weeks, we found that an algorithm based on biological and behavioral sensor data
could estimate depression severity evaluated by a clinician with high accuracy. The proposed study will further
refine our model in a sample of 100 adults with depression, assessed over 12 weeks. We anticipate that the
proposed study will enable the development of an objective, passive, sensor-based algorithm able to measure
depressive symptom severity. The identification of reliable, objective, passive assessment of depressive
symptoms with biosensors will have significant ramifications for the monitoring of depression, early detection
of response, remission and relapse and ultimately contribute to the advancement of precision medicine.

Public health relevance
Narrative The proposed project will create a novel method to assess depressive symptoms by harnessing modern machine learning analytics, phone sensors, and wrist-band sensors. Measurement-based treatment is considered optimal and the development of a valid passive, objective, behavioral and biological assessment of depressive symptoms that does not rely on clinician interviews will improve monitoring and ultimately improve treatment significantly. Ultimately, the ability to leverage a remarkable wealth of behavioral and biological data has the potential to transform the delivery of treatment for depression.